Addressing Under- and Overuse of Colorectal Neoplasia Surveillance Among Veterans

Background: Nearly one-third of all colonoscopies are performed for surveillance (i.e., follow-up) of previously
identified colorectal neoplasia. Despite existing evidence-based guidelines for colorectal neoplasia
surveillance, data show overuse of surveillance colonoscopy for low-risk and underuse for high-risk colorectal
neoplasia, even in integrated health systems such as the Veterans Health Administration (VHA). Overuse of
surveillance for low-risk neoplasia leads to exposure to unnecessary harms, wastes limited resources, and
creates barriers to access. Underuse of surveillance for high-risk neoplasia leads to increased risk for future
colorectal cancer (CRC). There is a critical need to address the imbalance of surveillance to optimize allocation
of limited colonoscopy resources in the VHA. Little is known about factors related to under- and overuse of
surveillance in this setting. Efforts to develop targeted interventions that address both underuse for high-risk
Veterans (who benefit most from surveillance) and overuse for low-risk Veterans (who benefit little or not at all)
are needed as the demand for colonoscopy far exceeds the capacity in the VHA.
Significance/Impact: Current efforts to improve access to colonoscopy resources are primarily focused on
shifting screening to non-invasive, stool-based tests. The overarching goal of this proposal is to develop and
pilot test an intervention to optimize surveillance by improving access to, and efficiency of, this costly and
limited resource at the VHA. Through this work, we seek to ensure delivery of high-quality, equitable, and
timely patient-centered care.
Innovation: Existing guidelines for surveillance intervals by themselves are not effective in the real-world. The
proposed work will shift the current paradigm for optimizing colorectal neoplasia surveillance by studying and
addressing factors at the patient-, provider-, and system-levels to identify targets for intervention. Cross-cutting
methods, using a theory-based, structured approach, will be used by an interdisciplinary team of experts to
improve colonoscopy resource use and access in the VHA.
Specific Aims: We will first characterize patient-, provider-, and facility-level factors associated with colorectal
neoplasia surveillance adherence and non-adherence (Aim 1). We will then conduct a formative evaluation of
barriers and facilitators from the perspectives of patients, providers, and staff to design an intervention that
optimizes surveillance use (Aim 2). And finally, we will pilot test the intervention to determine feasibility and
acceptability (Aim 3).
Methodology: In Aim 1, we will use national VHA data to identify Veterans who are between the ages of 50
and 75 years and have had either low- or high-risk colorectal neoplasia on their colonoscopies. We will then
characterize patient-, provider-, and system level factors associated with surveillance adherence and non-
adherence using a multilevel mixed-effects logistic regression model. In Aim 2, we will use qualitative methods
to conduct a formative evaluation of barriers and facilitators for patients, providers, and staff while using
Intervention Mapping as the framework to design our intervention. In Aim 3, we will pilot test our intervention to
determine feasibility and acceptability using a pre-post mixed methods approach.
Next Steps/Implementation: Findings from this project will directly inform an IIR proposal comprising a multi-
site Hybrid Type 1 randomized effectiveness-implementation trial of the intervention that we developed and
pilot tested. Effectiveness will be measured as adherence to surveillance for colorectal neoplasia. While this
proposal will focus on development of an intervention to improve underuse of surveillance for high-risk
colorectal neoplasia, interventions to reduce overuse of surveillance will be developed and tested in future
studies.

Public health relevance
Despite existing guidelines, a large proportion of patients with colorectal neoplasia (i.e., polyps and colorectal cancer (CRC)) undergo surveillance (i.e., follow-up) colonoscopy either sooner than recommended (constituting overuse) or later than recommended/not at all (constituting underuse). Surveillance overuse leads to increased healthcare costs, wastes limited resources, and leads to delays in care for those who need colonoscopy more urgently. Underuse increases risk for future CRC. Colorectal neoplasia is categorized according to risk for future CRC. Data show overuse of surveillance for low-risk neoplasia surveillance, but underuse for high-risk neoplasia. This non-adherence to guideline-recommended intervals may be due to patient-, provider-, and/or system-level factors. The proposed research will measure and identify factors associated with surveillance non-adherence in order to develop and pilot test an intervention to optimize appropriate use of surveillance, improving colonoscopy resource use and access in the VHA.